Sex and circuit-specific determinants of exercise-induced stress resilience

Project Summary
Women are more susceptible than are men to stress-related mood and anxiety disorders, underscoring the
importance of identifying strategies to promote stress resistance in women. Exercise affords broad benefits to
mental health in both sexes, but whether the degree of stress protection and underlying mechanisms differ
between sexes is unknown. We recently discovered that female rats are more responsive to the stress-buffering
effects of exercise than males. It takes voluntary wheel running (WVR) half the time to enable protection against
the depression- and anxiety-like effects of inescapable stress (IS) in female rats (3 wk) than it does in males (6
wk). Enhanced stress protection from exercise in females is an entirely unexplored resilience phenomenon. The
goal of this proposal is to examine the sex- and circuit-specific determinants of this process across multiple units
of analysis (molecular, cellular, circuits, sex, and behavior). VWR prevents the behavioral sequelae of IS by
constraining activation of serotoninergic (5HT) neurons in the dorsal raphe nucleus (DRN) during IS, but the
mechanism by which exercise constrains DRN 5HT activity is unknown. Our preliminary data provide strong
evidence that stress resistance in both sexes arises from engagement of sensorimotor circuits (dorsolateral
striatum; DLS) responsible for maintaining exercise. We have found that the DLS is positioned to inhibit DRN
5HT neurons through a direct GABAergic projection (DLS-DRN circuit), and 6 wk of VWR potentiates the activity
of the DLS-DRN circuit during IS. Importantly, although the DLS is required to maintain VWR behavior in both
sexes, the DLS governs VWR earlier in females (4 d) than in males (4 wk). Dopamine (DA) in the DLS contributes
to DLS-dependent behavior and females are known to have heightened stimulus-evoked dopamine (DA)
responses compared to males. This is likely the case with VWR, as just a few bouts of VWR activates D1
receptor-expressing neurons in the DLS of females, but not males. The rapid recruitment of the DLS during VWR
in females could accelerate plasticity in the DLS-DRN circuit required for constraining stress-induced 5HT
activity. Indeed, stress resistance from 3 wk of VWR in females depends on activity of the DLS-DRN circuit
during IS. These data suggest that once exercise becomes governed by the DLS, the DLS-DRN circuit now
responds actively to future adversity, thereby inhibiting the DRN & enabling stress resistance. We hypothesize
that DLS neural ensembles link exercise to stress resistance and are particularly responsive to exercise in
females, due to heightened DA responses to exercise in females compared to males. Intersectional genetic
approaches that tag, record, and manipulate neural circuit activity during initial exercise and later stress will be
used to 1) identify the role of the DLS in the development of exercise-induced stress resistance and accelerated
stress resistance in females, 2) determine the role of the DLS in the expression of exercise-induced stress
resistance in both sexes, and 3) identify the role of DA in driving accelerated stress resistance from VWR in
females and in determining whether an appetitive, sensorimotor experience enables stress resistance.

Public health relevance
Project Narrative The overall focus of this proposal is to investigate neural-circuit mechanisms of exercise-induced stress resistance and underlying sex differences. Results will enhance our knowledge of sex differences in response to exercise and could contribute to the development of more effective strategies for the treatment of trauma- linked disorders.